Immigration Policies, Dietary Acculturation, and Childhood Obesity.

PROJECT SUMMARY
One in four children in the United States (US) has at least one immigrant parent—more than a third of whom
came to the US from Mexico more than any other country of origin. Children of Mexican immigrants, in
particular those without documentation status, are exposed to psychosocial stress through their parents and
yet, nationally-representative analyses of how structural factors affect child dietary acculturation or obesity.
Mexican American children/adolescents experience disparities in obesity as compared to either their non-
Hispanic Whites or Mexican peers. The tapestry of state and local level immigration policy climates in the US
provides an opportunity to study their impact on immigrant families, both short and long-term. We will address
this research gap, by analyzing a novel data set of immigration policy climates linked to nationally-
representative data, to apply quasi-experimental and longitudinal methods. Aim 1 will study how the Illegal
Immigration Reform and Immigrant Responsibility Act Section 287(g), a local-federal immigration enforcement
program, initiation affects measures of child diet and obesity in the year following implementation, as compared
to the same locality the year prior to implementation. Then Aim 2 will expand the focus to include other
immigration enforcement programs (e.g. Secure Communities) and types of immigrant inclusion/exclusion in
state level policies (e.g. public health and welfare benefits, higher education, employment, and identifications)
across 10 years. We focus on children of Mexican immigrants given their obesity disparities and demographic
importance, but also compare our results to children of other immigrants, US-born Mexican Americans and
other US-born parents. Anticipated findings of this work will advance our understanding of population-level
structural determinants of obesity in Mexican American children, before weight trajectories have been set or
comorbidities arise, and may inform public health interventions for this vulnerable population.

Public health relevance
NARRATIVE Policies that restrict immigrants’ access to health and other services can erode both mental and physical well- being. We propose to conduct a novel data linkage to analyze how such policies and immigration enforcement associate with measures of diet and obesity for children of Mexican immigrants using nationally-representative data collected across 10+ years. Findings from this study will advance our understanding of the multiple levels of influence that immigration policy climates can impact children of Mexican immigrants, and may in part explain why this important and growing group faces a higher burden of obesity than their non-Hispanic White peers.